Transient loss of plasma membrane asymmetry in mammalian cells: mechanisms and function

PROJECT SUMMARY / ABSTRACT
A central feature of the plasma membrane (PM) of eukaryotic cells is the asymmetric distribution of various lipid
types across the two membrane leaflets. Maintaining such transbilayer organization requires investment of
significant energetic resources, implying an important functional role for interleaflet lipid segregation. A prominent
example are charged lipids like phosphatidylserine (PS): normally restricted to the cytoplasmic PM leaflet in
healthy cells, their permanent exposure on the exoplasmic face marks the cell for phagocytosis by macrophages.
The paradigm has recently been challenged by observations that PS temporarily flips to the outer PM leaflet
during antigen-induced activation in healthy immune cells. The purpose and mechanisms of this phenomenon
are wholly unknown, nor is it clear whether this redistribution is specific for PS, or rather leads to wholesale
lipidomic and biophysical scrambling of the two PM leaflets. To investigate these intriguing questions, we
propose to study the characteristics, regulatory mechanisms, and functional roles of this reversible lipid
scrambling during immune cell activation. In Aim 1, we will use advanced lipidomics and imaging techniques to
characterize the changes in membrane lipid organization during immune cell activation. We hypothesize that
antigen activation induces transient, highly localized, and non-specific lipid scrambling, in contrast to the
canonical permanent PS exposure associated with apoptosis. In Aim 2, we will identify the molecular
mechanisms responsible for this effect. Using super-resolution microscopy, we will monitor the nanoscale
organization of various lipid translocators, flipped lipids, and key machinery in the immune signaling cascade.
We expect to observe spatial segregation and confinement of these key molecules into specialized PM domains.
Finally, in Aim 3 we will examine the functional implications of lipid scrambling by evaluating the effect of PM
asymmetry on protein-membrane interactions. We hypothesize that activation-induced scrambling reduces the
charge density of the inner PM leaflet, leading to dissociation of charge-dependent signaling proteins from the
membrane. To test this hypothesis, we will use fluorescence microscopy in situ—as well as biophysical tools in
vitro and in silico—to examine the membrane binding affinity of polybasic-domain containing proteins, including
the oncogene Ras, in symmetric and asymmetric membranes. The successful execution of these aims will
produce important and novel insights into physiologically regulated changes in membrane organization and its
role in immune cell activation. Moreover, these studies will provide the first detailed lipidomic and biophysical
characterization of both unperturbed and functionally modified PM asymmetry. The findings may be extensible
to cell activation in a variety of other contexts, and are thus expected to have far-reaching impacts by revealing
new potential targeting for understanding and treating pathologies.

Public health relevance
PROJECT NARRATIVE Each cell in our body spends considerable resources to keep the charged lipid PS on the cytosolic leaflet of the plasma membrane (PM) because when PS is permanently exposed on the external surface, the cell becomes destined for destruction by macrophages. Intriguingly, recent studies have found that during healthy immune cell signaling, PS gets temporarily exposed on the exoplasmic PM leaflet, prompting questions about the mechanism and purpose of this phenomenon. In this research I am going to examine the distribution of all PM lipids in resting cells and during transient PS exposure, and investigate both the proteins that regulate this transient loss of PM asymmetry and its functional implications for the immune cell response.